Characterizing Neural Adaptation in Autism Spectrum Disorder

Project Summary
Autism spectrum disorders (ASD) are neurodevelopmental disorders characterized by impairments in social
interaction and communication, as well as the presence of repetitive behaviors and restricted interests. Given
that an estimated 1 in 68 children have ASD, and the high personal and societal costs associated with caring
for individuals with ASD, understanding the neurobiological underpinnings of ASD is an important public health
concern. It has been suggested that individuals with ASD are less able than typically-developing (TD)
individuals to predict events and optimize behavior based on these predictions. Here, I propose to test the
hypothesis that adults with ASD show reduced neural adaptation across multiple domains. Neural adaptation
could be a mechanism that supports prediction by differentiating between familiar and novel events. Recent
evidence suggests that other neurodevelopmental disorders such as dyslexia are characterized by broad
reduction in neural adaptation and in ASD reduced neural adaptation is associated with increased symptom
severity. An inability to adapt to a range of stimuli might have knock-on effects on social interaction,
communication, and motor behaviors. However, until this point no one has examined the specificity of neural
adaptation in ASD, and it is not known whether reduced neural adaptation is the result of bottom-up stimulus-
driven adaptation or top-down expectancy. I will recruit 20 TD adults, 20 age-matched adults with ASD, and a
small group of 8 children with ASD for a neural adaptation functional magnetic resonance imaging (fMRI) study
in which I will test the scope and limits of neural adaptation deficits across multiple domains in ASD. In a
second experiment, I will recruit an additional 20 TD adults and 20 age-matched adults with ASD to probe the
mechanism of reduced neural adaptation in ASD, and to determine in a second, independent cohort of
participants if results of the first experiment replicate despite heterogeneity in ASD. Lastly, I will examine the
dimensional relationship of neural adaptation to ASD traits continuously across participants. This work is
important as neural adaptation impairments are thought to contribute to multiple psychiatric and
neurodevelopmental disorders, including schizophrenia and dyslexia. Knowledge gained from this project will
provide a better understanding of the neural underpinnings of neural adaptation in ASD, and potentially inform
future neurobiological-based therapeutic treatments for ASD symptoms and other neurodevelopmental
disorders.

Public health relevance
Project Narrative The prevalence of autism spectrum disorder (ASD) is estimated at 1:68 individuals and rising, however the neurobiological underpinnings of the disorder are still unclear. It has been theorized that core ASD symptoms and traits may be caused by deficits in neural adaptation, and neural adaptation deficits underlie other neurodevelopmental disorders including dyslexia. This project will examine the neural underpinnings, domain specificity, and mechanisms of neural adaptation deficits in ASD using a combination of neuroimaging and behavioral measures, with the goal of characterizing basic mechanisms that underlie complex behaviors in ASD.